Targeting Trem2 in Atherosclerosis Progression

PROJECT SUMMARY
Atherosclerosis is driven by the deposition of low-density lipoprotein (LDL) cholesterol within the
aortic intima, forming a plaque. During plaque formation, monocytes infiltrate the sites of
atherosclerotic lesions where they differentiate into highly heterogeneous macrophage populations,
including lipid-loaded “foamy” macrophages which are a primary contributor to plaque progression.
Foamy macrophages are defined by their expression of Triggering Receptor Expressed on Myeloid
Cells 2 (Trem2), a known lipid sensor and key modulating factor of atherosclerosis disease outcomes.
Recent findings from our lab implicated Trem2 as a key factor modulating atherosclerosis disease
progression in vivo. We found that Trem2 mediated foam cell formation, and conditional deletion of
Trem2 in myeloid cells resulted in increased foam cell death, reduced macrophage proliferation, and
reduced plaque size. This study was followed by a Trem2 agonism approach, where we found that
stimulating Trem2 signaling enhanced atherosclerotic lesion burden. Using a Trem2 blocking
antibody, I will test the hypothesis that Trem2 blockade attenuates atherosclerotic plaque progression
by limiting macrophage lipid uptake and maintaining cell function. Next, I will tease apart the
molecular signaling downstream of Trem2 that mediates foamy macrophage formation. Ultimately, the
proposed aims will determine mechanisms of Trem2 signaling that reprogram foamy macrophage
function and illuminate the therapeutic potential of a Trem2 blocking antibody in atherosclerosis.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease is the leading cause of death worldwide, responsible for over 19 million deaths each year. An underlying cause of cardiovascular disease is atherosclerosis, the buildup of plaque in the arteries driven by cholesterol deposition and macrophage accumulation within the artery wall. This study aims to 1) determine the therapeutic efficacy of an antibody against Trem2, a lipid sensor, for management of atherosclerotic plaques, and 2) to understand Trem2 signaling versus lipid sensing function on macrophages.